Fully modified bispecific aptamer for effective combination therapy of neovascular ocular diseases

PROJECT ABSTRACT
Diabetic Macular Edema (DME) is the leading cause of blindness in the working age population. The anti-
VEGF agents Ranibizumab and Aflibercept are currently the standard of care for DME. However, these
treatments are far from optimal: ~40% of the DME patients have an inadequate response to the treatment.
Mover, patients have to receive regular intravitreal injections indefinitely, creating significant treatment burden.
Two more anti-VEGF agents have since been tested in phase 3 trials; although they moderately increased
drug duration (from 1-2 months to 3 months), both failed to further improve vision gain. Thus, relying on anti-
VEGF agents alone is clearly insufficient to improve efficacy.
Combination therapies, which combine an anti-VEGF agent with disease modifying agents that target other
important biomarkers such as Ang2 and VEGF-C/D, have shown great promise in further improving efficacy
and/or reducing treatment burden. However, they often require the use of multiple therapeutic agents and
sometimes multiple injections, which further increase the cost and treatment burden. In order to address this
shortcoming, the ideal next-generation DME treatment should meet the following criteria: a) small in size, in
order to achieve high molar dosage and longer duration of efficacy, and facilitate tissue penetration; b) devoid
of immunogenicity and immune-stimulatory effects, in order to ensure long-term safety; c) most importantly,
capable of inhibiting multiple biomarkers with one molecule, in order to improve efficacy without increasing
treatment burden and cost.
Aptamers are single stranded oligonucleotides that bind to molecular targets in a manner similar to monoclonal
antibodies (mAbs). Although aptamers were invented much more recently than mAbs, they have already
shown significant potential as ocular therapeutics: Macugen, the first anti-VEGF agent approved by FDA for
wet AMD treatment, is an aptamer; two more aptamers (Fovista and Zimura) have been tested in human trials
for multiple retinal indications, making aptamers one of the most evaluated modality for retinal diseases, with a
favorable safety profile and a clear regulatory pathway.
The purpose of this SBIR is to develop highly stable, multi-specific aptamers that may serve as the optimal
combination treatment for DME. To that end, the Aptitude team has accumulated extensive experience in
aptamer discovery. We have previously developed the Particle Display method that significantly improves the
aptamer performance. We have also developed the method to screen for the optimal linker for a bispecific
aptamer. Moreover, we have made further improvement to directly screen for fully modified aptamers that may
enable longer duration of efficacy. Our expertise in aptamer discovery is complemented by our collaborators’
expertise in DME preclinical research and clinical trials. If successful, this project has the potential of bringing
more efficacious and affordable treatment to DME patients.

Public health relevance
NARRATIVE DME is the leading cause of blindness in the working age population. The anti-VEGF agents are currently the standard of care for DME, but these treatments are far from optimal: ~40% of the DME patients have an inadequate response to the treatment; moreover, patients have to receive regular intravitreal injections indefinitely, creating significant treatment burden and resulting in high treatment drop-out rate in the real world. We propose to create a highly stable, bispecific aptamer that can target multiple biomarkers, thus both further improving treatment efficacy, and potentially reducing treatment burden by extending the duration of efficacy.